Advanced Mass Spectrometry Facility

Historically the facility has supported on the order of 40 PIs each year involved with around 70 annual report level projects with around two-thirds of these projects coming from the NIDDK. Although useful metrics for some things, the PI-count and project-count are oversimplifications. It is important to note that the amount of support provided to each project varies widely. For instance, support of small molecule chemists at NIDDK and a number of projects involving biopolymer analysis at NIDDK were very involved while most of the support provided to non-NIDDK labs involved one or two low staff time experiments. Support of Kenner Rice (NIDA) is a special case as he only recently moved to NIDA from NIDDK and has had a long-standing working relationship with the facility in all its historical forms. In addition to working in direct support of PI projects staff and resources are used to update methodology, adopting new and proven approaches of clear importance to the NIDDK PI community and in a limited number of cases developing new approaches when these are of immediate importance to on-going PI projects and otherwise consistent with the facilitys technical philosophies. In FY2017 the facility continued a modernization effort with completion of the acquisition of a new QTOF for the small molecule focused unit and initiating a complex transfer of existing DDA capable instruments for a single modern instrument. In a collaboration with Masison and Luecke the facility focused much of its internal developmental time creating an effective framework for performing DSSO specific cross-linking mass spectrometry analysis with the goal of introducing this at an expert level in the coming year.